HSR&D Research Career Scientist Award

Approximately 1 in 4 Veterans has a substance use or mental health disorder. Yet, the majority of these
Veterans do not receive treatment for these problems. My VA research program aims is to develop innovations
to improve access and engagement in substance use and mental health care for vulnerable populations, test if
these innovations are effective, and facilitate their implementation. This work involves investigating the
effectiveness and implementation potential of mobile health and peer-based interventions for Veterans who
struggle with homelessness and/or cyclical involvement in the criminal justice system. Such research is critical
to the VA’s mission, given that justice system involvement and homelessness disproportionately affect
Veterans and increase risk for chronic health problems and use of high-cost services.
Using a variety of sophisticated methodologies (e.g., hybrid trials, qualitative analysis), and in collaboration
with multidisciplinary teams from institutions in and outside VA and operational partners in VA’s Homeless
Program Office, Office of Mental Health and Suicide Prevention, and Office of Connected Care, my research
contributions focus on: (1) improving treatment engagement and outcomes for justice-involved and
homeless Veterans. My prior and future research in this area tests the effectiveness and implementation
potential of interventions that aim to reduce risk for criminal recidivism and acute care service utilization in this
high-need patient population; (2) evaluating virtual care services for Veterans with substance use and
mental health disorders. My prior and future research in this area studies the scalability and implementation
of mobile applications and video-enabled tablets to increase Veterans’ access to behavioral healthcare; (3)
developing, testing, and implementing peer-supported mobile health interventions. To date, my
research in this area has focused on developing and testing protocols for peers to support patients’ use of
mobile apps for self-management of alcohol use and mental health problems. My future research will seek to
advance implementation of this model of care into the continuum of behavioral health services for Veteran
primary care patients.
I have become a leader in these areas of research, as demonstrated by my peer-reviewed publications, grant
funding, invited memberships on study sections for VA and NIH, editorial positions for leading addiction and
mental health journals, and letters of support from non-VA colleagues. If I am fortunate enough to receive a
Research Career Scientist award from VA HSR&D, I will devote my full-time effort to research, mentoring, and
VA service activities as a distinguished leader on improving access and engagement in substance use and
mental health care for vulnerable populations.

Public health relevance
One in four Veterans has a substance use or mental health disorder; however, the vast majority of these Veterans go untreated due to a litany of barriers to access and engagement. My mission is to develop innovations to improve access and engagement in substance use and mental health care for vulnerable populations, test if these innovations are effective, and support their implementation into the VA’s health care system. These efforts primarily involve investigating the value of mobile health and peer-based interventions for Veterans who struggle with involvement in the criminal justice system and/or homelessness. This research is critical to VA’s mission, given that justice system involvement and homelessness disproportionately affect Veterans and increase risk for chronic health problems and use of high-cost services. Through my extensive collaborations with VA operational partners, I am committed to a VA research career to ensure that Veterans who are vulnerable to substance use and mental health problems have access to the highest quality of care.